Assessing Quality in Neurobehavioral Research

Project Summary The Good, the Bad, and the Ugly: Assessing Quality in Neurobehavioral Research The Organization for Teratology Information Specialists (OTIS) and Developmental Neurotoxicology Society (DNTS) will be having a joint meeting with The Teratology Society (TS), and from June 27-July 1, 2020. Presentations at the annual DNTS/TS/OTIS meeting focuses on effects of exposures to drugs and negative environmental conditions - especially exposure that occurs early in life - on the brain and behavior. The mission of OTIS is to support and contribute to worldwide initiatives for teratology education and research by empowering women, health care professionals and the public with accurate, current, and evidence-based information about the effects of exposures during pregnancy or while breastfeeding with the goal of enabling informed decision-making, reducing the risks of preventable birth defects, and facilitating professional development and communication. The mission of DNTS is to better understand, through animal and human studies, the developmental origins of nervous system diseases and prevent their occurrence. The joint meeting provides an opportunity for the societies to network, collaborate, provide professional development and training opportunities to members, and learn new ways in which to translate bench science to application and vice versa. As part of the 2020 conference programming, OTIS and DNTS will hold a symposium entitled “The Good, the Bad, and the Ugly: Assessing Quality in Neurobehavioral Research”. The objective of this symposium is to bring together developmental neuroscientists, neurotoxicologists, psychologists, toxicologists, epidemiologists, teratologists, teratogen information specialists, medical geneticists, physicians and genetic councilors from academia, industry, and government for a unique training opportunity to develop skills in translational science and communication. Attendees will learn from four qualified speakers about quality, challenges and limitations, and the interpretation of research methods and results. In addition, attendees will have opportunity to work together on a case study to practice and develop skills for the purposes of translating research to practice. Ample time will be allotted for discussion at the end of the symposium in order to allow participants to ask questions and integrate information. Thus, this symposium will provide both researchers and practitioners with opportunities for learning and skill development related to the conduct of research studies, interpretation of research results, and communication of scientific insights.

Public health relevance
Project Narrative The Good, the Bad, and the Ugly: Assessing Quality in Neurobehavioral Research This proposal requests funds for a symposium to be held jointly with the Organization for Teratology Information Specialists (OTIS) and the Developmental Neurotoxicology Society (DNTS) annual meeting in Charleston, SC, June 27-July 1, 2020. This symposium will bring together scientists and practitioners to train and develop skills in translational science and communication related to the conduct of research studies, interpretation of research results, and communication of scientific insights. Symposium speakers will present about quality, challenges and limitations, and the interpretation of research methods and results through lectures, case studies, and discussion.